Evaluating the impact of Basic needs Assessment and Support to Improve Colposcopy Show rate: The BASICS Trial

PROJECT SUMMARY/ABSTRACT
Each year, approximately 3.5 million individuals have an abnormal cervical screening result and are
recommended for medical follow-up, most commonly colposcopy. Colposcopy allows health providers to detect
pre-cancers and offer therapeutic interventions that may prevent cervical cancer. Unfortunately, between 37%
and 77% of patients are lost to follow-up after their abnormal screen and never receive appropriate care. Low
adherence to colposcopy is especially prevalent among Black patients, those with low income, and individuals
who are uninsured or have Medicaid, leading to socioeconomic disparities in cervical cancer incidence and
mortality. Our preliminary data from two university-based colposcopy clinics that provide care to these
underserved patients, show that colposcopy adherence improved from 50% to 83% after implementation of a
tailored phone call intervention reminding patients of their appointment and offering navigator assistance with
unmet social needs (e.g. utilities, transportation, food, shelter, clothing, safety). These pilot data suggest that a
social needs navigator program improves colposcopy adherence, but the lack of randomization limits the strength
of our conclusions. In this proposal, our objective is to test, and assess the readiness for implementation of a
colposcopy clinic-based social needs navigator program focused on five social determinants of health:
housing/shelter, food insecurity, personal and neighborhood safety, financial needs, and distress. This project
will test the hypothesis that this equity-focused, social needs navigator program can improve colposcopy
adherence among underserved patients. We will perform a randomized controlled trial in which 72 eligible
patients (low-income, uninsured, or on Medicaid) who are referred for colposcopy at Washington University
School of Medicine, are enrolled and then screened for unmet social needs and distress. They will then be
randomized 1:1 into either receive the social needs navigator program (n=36) or enhanced usual care (n=36). In
the navigator arm, a community health worker will provide four months of assistance tailored to their needs. In
the enhanced usual care arm, patients will be offered information and referral to United Way 2-1-1, a free, 24-hr
national helpline that connects callers with local resources. In specific Aim 1 we will determine the efficacy of our
social needs navigator program to improve colposcopy adherence. Aim 2 will assess the ability of our navigator
program to reduce unmet social needs and distress. Aim 3 will use the RE-AIM framework to evaluate metrics
of implementation and potential for dissemination. The proposed work will provide key data to launch a large,
pragmatic, multisite randomized controlled trial to rigorously test the effectiveness, implementation, and
maintenance of our social needs navigator program across different patient populations, community settings,
and healthcare organizations. If such a trial shows that our navigator program is effective, cost-effective, feasible,
and acceptable, it can be widely implemented to improve colposcopy adherence and equity in cervical cancer
prevention, incidence, and mortality.

Public health relevance
PROJECT NARRATIVE Individuals with low income often have inequitable access to colposcopy follow-up after an abnormal cervical cancer screen, leading to their disproportionately high rates of cervical cancer incidence and mortality. This proposal will evaluate whether a clinic-based, social needs navigator program—in which patients are screened for unmet social needs and distress, and paired with a community health worker for four months to resolve these needs—can improve adherence to colposcopy. If effective in this study and in a larger study involving more diverse patient subgroups, clinical settings, and geographic regions, widespread use of our navigator program could reduce disparities in cervical cancer prevention, incidence, and mortality of this disease.